Understanding how neuronal glucose metabolism changes in AD due to ApoE4

PROJECT SUMMARY
With rapid improvements to the quality of our healthcare, there is an urgency to better our understanding of age-
related diseases like Alzheimer’s Disease (AD). Clear connections between AD progression and glucose-
dependent bioenergetic deficits in the brain have motivated studies to uncover key biomarkers in AD diagnosis;
apolipoprotein E4 (ApoE4) has proven to be a hallmark indicator for patients at risk of developing AD. Astrocytes
are the primary manufacturer of ApoE4 in the brain, motivating most AD-relevant studies to focus on defining
the relationship between glial cells and ApoE4. Despite evidence connecting neuronal metabolic dysfunction to
the expression of ApoE4, the underlying biology of the metabolic changes is not understood. Our primary interest
with this project is to define the mechanisms through which ApoE4 expression and reduced neuronal glucose
metabolism are connected. We hypothesize that correcting disrupted mechanisms in ApoE4-expressing neurons
will result in a recovery of metabolic phenotypes to more closely resemble neurons expressing ApoE3. To test
our hypothesis, we have developed a paradigm that combines the targeted metabolomic analysis of human
induced pluripotent stem cell (iPSC) derived neurons in vitro with the spatial transcriptomic analysis of mice in
vivo. The in vivo model will be C57BL/6 mice with a whole-body knock in of human ApoE3 or ApoE4 on an
amyloid precursor protein (APP) background with the Swedish, Iberian, and Arctic mutations (APPNL-G-F). We will
perform spatial transcriptomics on the hippocampus, one of the first regions affected by AD progression, to
longitudinally track the most differentially expressed genes due to ApoE4. The human iPSCs expressing either
the E3 or E4 isoform of ApoE allows for a nearly pure (>99%) neuronal culture. The whole neuronal metabolome
is probed with uniformly 13C labeled glucose ([U-13C] glucose) to quantify which metabolites in neurons are
being derived from glucose. The metabolome of the ApoE3 and ApoE4 expressing neurons will be compared to
define the primary differences in how glucose is metabolized between neurons based on their ApoE isoform. We
will use CRISPR inhibition or activation (CRISPRi/a) to alter the expression of our genes of interest in a targeted
metabolomics study to evaluate the functionality of each gene in relation to glucose metabolism in neurons. We
will then evaluate whether metabolic recovery is achieved through comparing ApoE4 neurons to ApoE3 neurons
based on equivalence of glucose-derived metabolites, cytosolic ATP and glucose levels, and cell survival.
Successful completion of these aims will inform future studies focusing on metabolic recovery in neurons as well
as providing candidates for therapeutic targets against neurodegenerative disease. The research will be
conducted at Gladstone Institutes and UCSF under the mentorship of Dr. Ken Nakamura along with key facilities
such as the Stem Cell, Genomics, and Bioinformatics Cores to complete the proposed work. The training plan
spans a 3-year period focused primarily on research with 1.5 years spent per aim. The plan also sets aside time
essential for nurturing academic science through conferences, mentoring, and university/community programs.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease progression is characterized by cellular expression of ApoE4, reduced metabolism in the central nervous system, and protein pathologies involving Tau and Amyloid-Beta. The roles of neuronal glucose metabolism and neuronal ApoE4 in Alzheimer’s Disease development are not well understood due to both the complex metabolic interactions between neurons and glia. We will therefore clarify the role of neuronal metabolism in the progression of Alzheimer’s Disease through a combination of genomics, metabolomics, and targeted validation of these changes through quantification of protein-level changes and intracellular ATP levels, enabling us to capture a complete picture of how neurons metabolically respond to their expression of ApoE4.